Antigenic determinants of asthma-associated allergens for design of immunotherapy

TITLE: Antigenic determinants of asthma-associated allergens for design of immunotherapy
PROJECT SUMMARY/ABSTRACT
Asthma is the most common chronic disease among children. One in twelve children are affected. Asthma is a
major cause of missed school days and disproportionately affects black, Hispanic and minority populations, and
rural Americans who lack access to health care. The CDC estimates that the economic costs of asthma are
~$80 billion. The condition is strongly associated with economic disparities, especially low-income populations
living in sub-standard housing. Allergic reactions to potent allergens produced by house dust mites, cat, and
dog are major risk factors for the development of asthma and for emergency room admission with asthma.
House dust mite allergy affects 85% of asthmatic children, while cat and dog allergens account for >500,000
ER visits per year. The molecular determinants on these allergens that are the targets of allergy antibodies are
unknown. The goal of this application is to use human IgE monoclonal antibodies derived from allergic
patients to define the allergenic structure of dust mite, cat, and dog allergens for potential development
of novel forms of immunotherapy. Mite group 1 allergens are cysteine proteases that contribute to lung
inflammation in asthma, whereas group 2 allergens are lipopolysaccharide binding proteins. Fel d 1 and Can f 1
are uteroglobins and lipocalins, respectively. Allergen-specific human IgE monoclonal antibodies (mAb) will be
produced from children and adults with allergic asthma as they occur in vivo. Allergens will be co-crystallized
with recombinant IgE antibody constructs. The key amino acids involved in IgE antibody binding will be
identified and modified. The specific aims are: 1) Production of allergen-specific human IgE mAb and analysis
of their immunoreactivity; 2) Mapping of actual IgE binding epitopes on dust mite, cat, and dog allergens by X-
ray crystallography; and 3) Site-directed mutagenesis of IgE antibody epitopes for expression of hypoallergenic
mutants as candidates for immunotherapy. An analysis of the association between allergen-specific IgE
antibodies from the human repertoire and the epitopes recognized by these IgE antibodies will be performed.
Unique experimental data sets of three-dimensional structures of B-cell epitopes will be generated to expand
databases used for developing tools for B cell epitope prediction. Most importantly, this project will define IgE
antibody responses to cat, dog, and mite allergens and will provide the structural basis for rational design of
hypoallergens and IgG blocking antibodies for therapy. In Aim #3, IgE antibody binding to the epitope mutants
will be analyzed by immunoassays and cell mediator release assays, and T cell reactivity will be evaluated.
Mutants will be compared, and hypoallergenic forms will be selected for the design of vaccines for
immunotherapy of cat, dog, and mite allergy. The capacity of the mutants to induce a protective immune
response will also be tested in vivo in a mouse model of passive anaphylaxis. Defining the allergenic structure
of the most important allergens associated with asthma will be a major outcome of this study and is anticipated
to result in new diagnostic and therapeutic strategies for treatment of allergic disease.

Public health relevance
PROJECT NARRATIVE IgE sensitization to indoor allergens is associated with development of asthma, a disease that affects 26 million people in the U.S. Monoclonal IgE antibodies specific for asthma-associated allergens will be isolated from allergic symptomatic subjects as they occur in vivo, to analyze IgE antibody epitopes on mite, cat, and dog allergens and their associated IgE antibody repertoire. The goal is to elucidate the importance of the intrinsic properties of these allergens on their role in causing allergic disease, and to produce hypoallergenic mutants that will be tested for B and T cell reactivity, to generate information that will facilitate a rational design of allergy vaccines.